Evaluating the Ability of the Invasive Asian Longhorned Tick, Haemaphysalis longicornis, to Maintain and Transmit North American Tick-borne Viruses

PROJECT SUMMARY & ABSTRACT
The invasive Asian Longhorned tick, Haemaphysalis longicornis, is native to eastern Asia but recently
established populations in the United States and continues to expand its geographic range. This is a public
health threat, because in its native range, H. longicornis is an established vector of viruses closely related to
Heartland virus (HRTV) and Deer tick virus (DTV), which are the two main North American tick-borne viruses.
The capacity of H. longicornis to transmit North American tick-borne phleboviruses (HRTV) and flaviviruses
(DTV) is unknown, leaving us unaware of the epidemiologic impact of this invasive tick species. The overall
objective for this application is to assess the ability of H. longicornis to acquire, maintain, and transmit North
American tick-borne phleboviruses and flaviviruses. The central hypothesis is that H. longicornis is a competent
vector for HRTV and DTV, and co-feeding transmission of HRTV or DTV between infected native ticks and
uninfected H. longicornis ticks can occur in the absence of host viremia. The rationale for this project is that if
H. longicornis is capable of maintaining HRTV and DTV in tick populations and transmitting these viruses to
mammalian hosts, we can begin to forecast evolving epidemiologic and transmission dynamics of these viruses
in North America. The central hypothesis will be tested by pursuing two specific aims: 1) Assess the vector
competence of H. longicornis ticks for HRTV and DTV; and, 2) Investigate whether non-viremic transmission of
HRTV or DTV occurs between infected native ticks (Amblyomma americanum or Ixodes scapularis) co-feeding
on the same host with uninfected H. longicornis. Under the first aim, H. longicornis will be infected with HRTV or
DTV, and viral replication kinetics in the tick will be examined. To assess horizontal transmission of HRTV and
DTV, infected H. longicornis will receive a bloodmeal and exposed hosts will undergo serology and viremia
screening. After molting to the next life stage, ticks will be tested for the presence of virus to evaluate vertical
transmission. For the second aim, uninfected H. longicornis nymphs will be co-fed on the same host with HRTV-
infected A. americanum or DTV-infected I. scapularis adults. The H. longicornis nymphs will be tested for the
presence of virus at different feeding proximities on the host. The proposed research is conceptually innovative
because it is the first to evaluate H. longicornis’ vector competency for the North American viruses, HRTV and
DTV, which circulate in regions where invasive H. longicornis populations recently established. This contribution
will be significant because it frames the basic biology of this invasive tick species in relation to North American
tick-borne viruses, which is extremely important as we seek to understand the public health implications of H.
longicornis establishment in regions of North America where these viruses are endemic.

Public health relevance
PROJECT NARRATIVE The recent establishment of invasive Haemaphysalis longicornis tick populations in North America represents a new and emerging disease threat as this tick transmits viruses in its native range in East Asia that are closely related to tick-borne viruses naturally circulating in North America. If H. longicornis ticks are capable of maintaining and transmitting North American viruses, such as Heartland virus and Deer tick virus, increased human cases will result. Elucidating H. longicornis vector competency for North American tick-borne viruses is critical to understanding the epidemiologic impact of this invasive tick species and to implementing appropriate diagnostics and prophylaxes for humans bitten by H. longicornis.